A Novel Articulating Stylet for Improving First-Pass Intubation Success

SUMMARY
Endotracheal intubation (ETI) is performed for surgery under general anesthesia, and to provide oxygen during
cardiac arrest and respiratory failure. To perform this procedure, medical personnel use both hands: the left hand
inserts a laryngoscope to provide visualization, and the right hand maneuvers the endotracheal tube (ETT) into
the patient’s airway. Most often, the ETT is preloaded with a stylet device to help guide the ETT through the
curving airway path and into the trachea. However, there can be complications if the pre-formed curve of the
stylet does not correspond to the anatomical curve of the patient. Common patient characteristics including
obesity, a short, thick or immobile neck, small mouth, or receding chin, especially in combination, may require
multiple attempts. In emergency situations multiple attempts can exacerbate physiologic co-morbidities such as
hypotension or hypoxia. Multiple large studies have established that inability to intubate on the first attempt is
strongly correlated with patient injury. In aggregate, difficult intubation and resultant patient injuries account for
over $1B excess costs in the U.S. annually. Visualization has undergone a tremendous technological advance,
thanks to video laryngoscopy, but improvement in steering the ETT has lagged behind. SmartAirway addresses
this issue with an innovative, articulating stylet, the SmartStylet, that can be adjusted to the patient’s internal
airway curvature by the operator in real time to promote first-pass intubation success. Using a uniquely designed
spring-steel mechanism, the proposed device is able to flex an onboard, standard, off-the-shelf ETT 60 degrees
anteriorly and 15 degrees posteriorly, while in the body and using just one hand. Stylets on the market today
only allow for adjustments of the device after interrupting the procedure, removing the styletted ETT, and re-
bending it outside the body. Then the entire procedure is repeated. While our working prototype has
demonstrated its ability to flex and adjust the ETT’s shape during intubation on a manikin, there is further testing
needed before it can be produced and used by healthcare providers. The proposed work in this Phase I proposal
will accelerate this through the following aims: 1) Mechanical optimization of the SmartStylet by minimizing the
hand-grip force required to flex the tube through enhanced leverage, coating the moving parts with lubricating
materials used in stylets today, and other possible design enhancements and mechanical testing, and 2)
Demonstration of device efficacy and expected superiority compared to the two most commonly used stylets in
clinical practice in a preclinical study in the hands of anesthesiology residents and fellows using a manikin model
under routine and difficult set-ups. The inability to properly steer the ETT contributes to the majority of failed
intubation attempts, and is due to the limitations of current devices; our device directly addresses this technology
gap. The adoption of the SmartStylet has the potential to significantly decrease the number of attempts and
complications associated with difficult intubation, improve patient outcomes, and decrease healthcare costs.

Public health relevance
NARRATIVE Severe patient injury, including esophageal perforation, tracheal laceration, vocal cord damage, bleeding and asphyxiation can occur when multiple attempts are needed to position an ETT. Despite technical advances in the visualization portion of intubation, currently available devices for steering the tube into place fall short and contribute to this iatrogenic patient harm. SmartAirway is developing an innovative articulating intubation stylet, the SmartStylet, to overcome the limitations of current devices and allow healthcare workers to precisely steer the tube into the correct position, in real time and on the first intubation attempt.